Kinetics of Red Blood Cell Clearance in Chronically Transfused Children with Sickle Cell Disease

Project Summary
Sickle cell disease (SCD) carries significant morbidity as a result of red blood cell (RBC) sickling and
hemolysis. Stroke is one of the most devastating sequelae of SCD. Chronic transfusion therapy (CTT) reduces
stroke risk by (1) supplying normal, non-sickle RBC to circulation, thereby reducing the percentage of
endogenous sickle RBC in circulation, and (2) maintaining a higher hemoglobin (Hb), thereby suppressing
erythropoiesis of new sickle RBC. While the efficacy of CTT in stroke prophylaxis is well-established, nearly
45% of children continue to have silent or overt strokes despite CTT. The failure of CTT to prevent stroke
events may be related to inadequate reduction of circulating sickle RBC and erythropoiesis. The amount of
circulating sickle-RBC is related to the survival kinetics of both transfused RBC and endogenous sickle RBC. In
a large, longitudinal analysis of CTT in SCD, we found wide variation in the survival of donor RBC following
transfusion, with faster clearance associated with patient immune features (historical RBC alloimmunization
and spleen presence) and with donor RBC glucose-6-phosphate-dehydrogenase (G6PD) deficiency. To better
understand the roles of patient and donor factors in the survival and clearance of transfused RBC, we propose
a mechanistic, clinical trial during chronic transfusion episodes in patients with SCD, in which a small aliquot of
each transfused unit is labeled with biotin conjugated to RBC surface proteins, to safely identify and measure
the in vivo survival of donor RBC. Aim 1 will examine the relationships of the recipient’s immune system (past
alloimmunization, splenic volume, and markers of reticuloendothelial system function) on the post-transfusion
survival of biotin-labeled donor RBC. Aim 2 will examine the relationships of donor RBC G6PD levels and
donor RBC metabolomics with the in vivo survival and changes in donor RBC senescence markers.
Completion of these aims will increase our understanding of mechanisms for the variability in RBC survival
during CTT, identifying donor and recipient risk factors for decreased RBC survival. Ultimately this knowledge
will inform the management of CTT to improve the prevention of strokes in SCD. The applicant, Dr. Yee, is a
pediatric hematologist and an emerging clinical researcher in SCD, with a master’s degree in clinical research
and experience with pilot and prospective studies of patient-oriented research in SCD. Dr. Yee has identified
an exceptional mentorship team with expertise in RBC survival studies and biotinylation, donor RBC
metabolomics, and clinical research in SCD. The candidate's short-term career goals for this K23 application
are to 1) Develop formal expertise in transfusion medicine; 2) Expand expertise in conducting prospective,
interventional clinical research in pediatric SCD and transfusion medicine; 3) Learn the use and interpretation
of biotinylation of RBC transfusion to study transfusion survival in vivo. The candidate's long-term career goals
are to improve transfusion and cellular therapies with a personalized approach to blood transfusion in children
and adults with SCD and to improve the clinical outcomes of transfusion and other SCD therapies while
decreasing toxicity and adverse events.

Public health relevance
Project Narrative Understanding patient and donor-related factors that influence the survival of red blood cell transfusions in children with sickle cell disease will provide information on mechanisms for improvement of hematologic and clinical responses to chronic transfusion therapy. This new information ultimately will help us to 1) identify reasons that patients may have poor responses to therapy and 2) modify donor aspects of transfusion therapy to improve treatment responses and decrease disease-related morbidity.